Targeting complement-induced IL-15 trans-presentation by human endothelial cells

7. Project Summary/Abstract
Complement may be activated in the peri-transplant period by insults such as ischemia reperfusion injury or
binding of preformed host-anti-graft antibodies as well as post-transplant by binding of de novo donor specific
antibody. In these settings, complement membrane attack complexes (MACs) are deposited on allograft
endothelial cells (ECs) which increases the capacity of graft ECs to activate alloreactive host T and NK cells,
providing a mechanistic link between such insults and an increased incidence and severity of T cell-mediated
rejection (TCMR) without overt EC damage. We have shown that MACs are internalized and initiate IL-1
synthesis, processing and secretion followed by IL-1-mediated autocrine/paracrine activation of human ECs. A
key component of this activation response is expression of IL-15/IL-15R complexes on the EC surface that
can be trans-presented to circulating lymphocytes. Blocking IL-15 trans-presentation reverses much of the
MAC-induced augmentation of EC alloimmunogenicity. We hypothesize that gene editing of graft ECs ex vivo
prior to transplant will reduce the severity of TCMR and prolong graft survival while still enabling the host
immune system to respond to and control graft infection. Here we propose to develop approaches to do so, but
preliminary data have revealed that the response of ECs to MAC and IL-1 is unexpectedly complex. Human
ECs transcribe multiple different versions of IL-15 mRNA and increase these transcripts in response to IFN- or
MAC/IL-1, but only MAC/IL-1 leads to surface expression. The MAC/IL-1 response requires activation and
nuclear uptake of NF-B, but NF-B appears to regulate IL-15 translation rather than transcription, possibly
mediated by miRNA. Furthermore, co-induction of IL-15R, rather than pre-existing copies of this protein, is
required for endogenous IL-15 surface expression. It is unknown if exogenous IL-15 can be trans-presented by
ECs. We need to better understand these pathways in order to exploit them therapeutically. In this R21, we will
identify and quantify the IL-15 mRNA species expressed by cultured human ECs that encode surface
expressed protein isoforms and elucidate the mechanism of their translational control (aim 1). We then
propose to optimize strategies for the elimination of MAC-induced IL-15 surface expression and trans-
presentation using CRISPR/Cas9 gene editing and determine if and how this can be achieved using mRNA
transfection while preserving EC homeostatic functions (aim 2). We will use the results of these studies to
guide our future approach to gene edit human graft EC in ex vivo machine perfused organs.

Public health relevance
8. PROJECT NARRATIVE Complement may be activated by multiple mechanisms, such as ischemia reperfusion injury or anti-donor antibodies, depositing membrane attack complexes (MACs) on the surface of the endothelial cells (ECs) that line the blood vessels of the graft. Graft ECs internalize MACs, triggering a complex and incompletely understood process that results in expression of IL-15 on the EC surface facing the blood where it can boost the activation of circulating host T lymphocytes and result in graft rejection. In this Exploratory/Development (R21) grant, we propose to elucidate the complex regulation of IL-15 cell surface expression in human ECs (aim 1) and optimize a genetic therapy approach (aim 2) that can be adapted to block this process in human organs undergoing pre-transplant ex vivo machine perfusion.